Core A: Administrative, Career Development, and Research Integration Core

The Administrative, Career Development and Research Integration Core of the Center for Molecular Epidemiology at Dartmouth (“Administrative Core,” Core A) is the driving force that underpins the Center’s achievements. It will support the Center’s goals of: 1) advancing the Center by enhancing the governance and operational structure of the Center, broadening its reach, and engaging stakeholders in the research direction and priorities of the Center; 2) facilitating the state-of-the-art Biorepository and Biospecimen Resource Facility Core (Scientific/Technical Core B); and 3) strengthening the pipeline of molecular epidemiologists by recruiting, mentoring, and providing career development resources in collaboration with the Pilot Project Program. The Core will be responsible for the fiscal management, reporting, and regulatory compliance needs of the Center and for ensuring adherence with NIH policies and institutional standards. The Core will further promote resource sharing and scientific exchange between Center investigators, IDeA and non-IDeA programs, and the scientific and broader community by: (1) making the Center’s research resources known and widely available; (2) organizing regular Center symposia, training, and mentoring activities, and workshops on emerging topics in the field of molecular epidemiology; and (3) educating and engaging stakeholders to inform research priorities for the Center. The Core will work collaboratively with the Center for Program Design and Evaluation to rigorously evaluate and monitor the progress and achievements of the Center to enhance effective and timely operations, identify obstacles, and create lasting solutions. The Center Director, Associate Directors, and Center Coordinator will comprise the leadership team who will report to the Provost and Dean of the Geisel School of Medicine, and together with accomplished leaders and biomedical scientists, will direct the activities of the Core. An External Advisory Committee of prominent scientists, a Community Advisory Board of key stakeholders, and institutional leaders from Dartmouth, the Dartmouth Health system, and the Dartmouth Cancer Center will provide guidance to the Center. By fostering discoveries and synergies with local, regional, and national partners and by being responsive to the IDeA Program and other major initiatives, the Core will accelerate the Center’s impact in the field of molecular epidemiology to improve human health lifelong.